Leadership, Planning and Evaluation

3.0 Abstract: Leadership, Planning, and Evaluation
The University of Maryland Marlene and Stewart Greenebaum Comprehensive Cancer Center (UMGCCC) has
a robust program planning and evaluation process, which includes several groups with internal and external
expertise. These groups monitor the scientific activities of UMGCCC, evaluate new scientific opportunities, and
define future strategic scientific needs of the Cancer Center with regard to personnel, facilities, and technologies.
UMGCCC leadership includes a team of highly qualified scientists and administrators who work together to
monitor the status of the Cancer Center and move it forward. UMGCCC director Dr. Kevin Cullen meets regularly
with Dr. Richard Eckert, UMGCCC deputy director, and the P30 executive committee, which comprises the
associate directors and administrative leadership. This group is responsible for establishing scientific priorities
for the Cancer Center, including recruitment priorities. It also monitors all the internal and external planning and
evaluation functions described in this section.
In addition, UMGCCC regularly engages external experts to evaluate and advise UMGCCC leadership on the
structure and function of its shared services and research programs. Each shared service and program has been
independently evaluated and received formal recommendations.
UMGCCC is fortunate to rely on the expertise and counsel of the External Scientific Advisory Committee, which
consists of one senior Cancer Center administrator and 10 senior cancer investigators from around the country,
all of whom provide a range of expertise in Cancer Center clinical, translational, and population research as well
as administration.
Program planning and evaluation are critical to the overall function of UMGCCC and its evolution. Numerous
changes that have resulted from this process are evident in this grant application and reflect the commitment of
UMGCCC to conduct regular, comprehensive evaluations of all its components.